Metabolomic Screening of Biomaterials for MSC Culture

PROJECT SUMMARY
Mesenchymal stem/stromal cells (MSCs) have transformative healthcare potential, but to achieve
therapeutic cell numbers, MSCs must be culture expanded. On tissue culture poly(styrene), however,
MSC expansion is constrained by replicative senescence, and cells experience progressive loss of
therapeutic potency with continued expansion. The lack of large numbers of reliably potent therapeutic
cells is considered one of the most critical roadblocks to the success of MSC clinical trials. However,
screening of improved MSC culture conditions has been hampered by the fact that there are no
characterization tools that might allow prediction of cell fitness early in culture. Metabolism is the most
dynamic level of cellular response, and metabolomics may enable the identification of early signatures
associated with optimal cell product quality. Therefore, it is hypothesized that early metabolomics data
from MSCs cultured on biomaterials will allow prediction of cell fitness later in culture and thus promote
development of materials to promote a desired cell phenotype during expansion.
The objective of this application is to determine the relationship between biomaterial carrier
properties, cell metabolism, and maintenance of MSC fitness during expansion. This objective will be
approached through the following specific aims: 1) Evaluate the effects of altering ligand type and
stiffness of the biomaterial substrate on metabolism and replicative senescence of human MSCs during
expansion in serum, and 2) Evaluate the effects of the substrate heparin content and pattern of initial
seeding on metabolism and replicative senescence of human MSCs during expansion in serum-free
conditions.
The proposed work is innovative because it uses early cellular metabolic responses to design material
substrates that will promote cell expansion without senescence in a range of media compositions. Results
from these studies are expected to have an important positive impact because they will lead to more
efficacious expansion protocols for MSCs and thus produce more effective cell-based therapies for a wide
variety of diseases.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because results from this study are expected to lead to improved cell-based therapies for a wide variety of chronic pathologies. These studies will also result in greater understanding of how culture conditions influence cell metabolism and expansion. This is relevant to the NIH's mission as this research provides new methodologies that will lead to better treatments for chronic diseases.